Investigating Cis and Trans Regulation of Complex Phenotypes

PROJECT SUMMARY/ABSTRACT
Despite its importance, we do not understand the impact of variation in the regulatory genome on complex
traits. Currently, the field lacks the genetic models necessary to address this relationship systematically, so little
is known about the effect of quantitative variation in gene regulation on quantitative phenotypic output. Tomato
development offers a high-throughput genetic system to address this gap; variation in a tomato enhancer
produces a spectrum of gene expression and quantitative phenotypic output. The rationale of the Research
Training Plan is to use this system to characterize the phenotypic and molecular consequences of genomic
variation at the interface of transcription factor-cis regulatory motif binding.
In Aim 1, the applicant Dr. Sophia Zebell will train with mentor Dr. Zachary Lippman in quantitative
genetics during the K99 phase, using CRISPR base editing to generate deep sequence variation in cis-regulatory
motifs, and characterizing the molecular and phenotypic consequences of variants with RNA-sequencing,
quantitative phenotyping, and genotype-to-phenotype modeling. In Aim 2, Dr. Zebell will use epistasis analysis
to investigate the quantitative genetic relationship between engineered and natural cis and trans regulatory
variation, complementing genetic experiments with molecular biology to assess transcription factor-DNA binding
affinities to motif variants, including massively multiparallel titration curves and microscale thermophoresis. In
the R00 phase (Aim 3) Dr. Zebell will leverage the genetic interactions characterized in Aim 2 to address genetic
variation in transcription factor DNA-binding domains of different families using a CRISPR-mediated suppressor
screen approach to evolve factors that effectively bind cis-regulatory motif variants. Aim 3 will employ SNP-
SELEX to assess binding of native and evolved transcription factors to pan-genome-wide cis-regulatory SNPs.
Candidate Dr. Sophia Zebell is trained in the molecular biology of transcription factors, with six
publications since 2013. The Career Development Plan will allow Dr. Zebell to gain new technical skills in high
throughput genetics and genomics, tissue culture and transformation through mentored research and
coursework, and career skills through workshops and practical experience. Mentor Dr. Zachary Lippman is an
expert in genetics who has trained 10 productive postdocs, and Advisory Board members Dr. Joyce Van Eck
(transformation), Dr. Yiping Qi (genome editing), Dr. Yuval Eshed (gene regulation), and Dr. Justin Kinney
(computational biology/biophysics) offer complementary expertise. The highly collaborative, world-class
quantitative genetics research environment of Cold Spring Harbor Laboratory and the Lippman lab are the ideal
place to acquire this training. In summary, this proposal presents a plan for Research Training and Career
Development to establish Dr. Zebell as an independent investigator while offering insights into an understudied
area of the genome with important implications for a wide variety of human diseases.

Public health relevance
PROJECT NARRATIVE Variants in the noncoding genome have profound effects on human health, but their role in gene regulation is not always clear. This study will investigate the role of quantitative epistasis between cis and trans regulatory variants in regulating complex traits. Insights from this work will advance basic and applied fields of genetics, providing insights into the tunability of gene expression to promote the development of therapeutics for gene regulatory diseases.